Longitudinal Determinants of Thriving and Well-Being in Venezuelan Crisis Migrants

Project Summary
The United Nations estimates that more than 8 million Venezuelans have fled their home country since 2015.
At present, Venezuelans are among the fastest-growing immigrant groups in the United States (U.S), filing two
times the number of US. asylum applications annually as citizens from any other country. Remarkably, almost
no systematic research—excluding our formative work—has examined the wellbeing of Venezuelans in
diaspora. Although prior research has advanced our understanding of this population and its challenges, the
role of intrinsic and extrinsic strengths among Venezuelan crisis migrants during resettlement and over time, as
well as how such factors relate to mental health, thriving, and flourishing across countries remains unknown.
To address this critical research gap, the present diversity supplement is aimed to: Aim 1, use qualitative
research to examine underlying mechanisms of thriving and flourishing among adult Venezuelan crisis migrant
in the U.S. and Colombia. Aim 2, employ prospective surveys to understand how intrinsic and extrinsic
strengths promote thriving and flourishing, flourishing, and how they relate to stressors and behavioral health
during and after resettlement. Aim 3, engage with key stakeholders to disseminate our mixed-methods findings
in an effort to promote thriving and flourishing among Venezuelan crisis migrants.
The comparison with Venezuelans in Colombia is essential for identifying aspects of life in the US that may
uniquely contribute to both risk and well-being among crisis migrants, and for informing context-specific and
cross-national solutions to a hemispheric crisis. Grounded in cultural stress theory, a strengths perspective,
and positive epidemiology, we will examine the interplay between strengths and both pre-migration risk factors
and post-migration cultural stressors and how they influence behavioral health outcomes. In addition to
quantitative and qualitative analysis, this study will use a convergent mixed-methods design to compare
qualitative and quantitative data. We will collect quantitative and qualitative data simultaneously (in parallel),
and conduct the data analyses separately. We will compare the quantitative and qualitative results to produce
an integrated analysis and identify whether there was convergence or divergence between the results. Given
the ongoing large number of Venezuelans migrating, this work is particularly relevant and timely.

Public health relevance
Project Narrative Despite Venezuelans being among the fastest-growing migrant groups in the US and Colombia, there is limited knowledge on the interplay between key strengths, behavioral health outcomes, and well-being among this population during resettlement and over time. The proposed study aims to identify and compare key elements vis-à-vis thriving, flourishing, and behavioral health of Venezuelan crisis migrants in the US to those who relocated in Colombia. Findings from this diversity supplement will inform evidence-based policy efforts as well as the development of innovative and culturally relevant responses to future crisis migrations and the promotion of crisis migrants’ well-being.